Integrative Genomic Applications to Understand the Etiology of Unsolved Craniofacial Anomalies

Craniofacial abnormalities of the face or head are among the most common birth defects in the United States and represent a large public health burden. Despite a considerable commitment of resources to research on the biological etiology underlying a diverse spectrum of craniofacial disorders, the mechanisms leading to these congenital abnormalities remains largely uncharacterized. Defining the genetic etiology behind these disorders will not only improve diagnosis and screenings of these disorders, but also improve treatment. In a recent study, we investigated the genetic etiology behind arhinia, an extremely rare craniofacial malformation defined by the complete absence of the external nose. Sequencing analysis within this arhinia cohort observed a significant accumulation of rare heterozygous missense mutations in SMCHD1 in 84% of independent arhinia cases none of which were present in 60,706 control subjects from the exome aggregation consortium (ExAC). SMCHD1 is an epigenetic regulator that has been previously been implicated in a digenic form of muscular dystrophy (FSHD2), but has never been associated with any craniofacial disorders. Aim 1 will explore the mechanism SMCHD1 causes arhinia and also provide an invaluable training experience in functional genomics using both epigenetic and transcriptome analyses of patient derived cell lines (Aim 1a) and cartilage tissue from smchd1 knockdown zebrafish (Aim 1b). Aim 2 will transition into more common craniofacial disorders by pursuing novel gene discovery in 678 trios with an orofacial cleft (OFC) affected proband that have undergone whole genome sequencing (WGS). Relying on cutting edge WGS analysis, I will delve into the mutational spectrum that is cryptic to conventional genetic testing and therefore has never been characterized in an OFC cohort. Notably, these studies will facilitate a natural transition into the independent R00 phase, which will bridge the expertise acquired in functional genomics and craniofacial biology during the K99 with my existing expertise in genome structure to perform the first integrated whole-genome and whole-transcriptome gene discovery effort in an OFC cohort in Aim 3. This will provide an unprecedented view of both the genome and transciptome, which will lead to superior gene discovery and mechanistic insight. Overall, this project represents a unique training opportunity to develop skills in each of my targeted areas of career development by gaining access and expertise in a diverse set of functional genomics technology and will provide me with broader exposure to the field of craniofacial genetics. Upon completion of the K99 training proposed in the grant, I will be well suited for an independent faculty position. Moreover, while the training potential of the project is high, the studies proposed will have a significant impact on the field of craniofacial genetics and are ideal to seed future grants as I ultimately develop my own independent research program.

Public health relevance
Craniofacial defects are among the most common birth defects in the United States and their treatment represents a costly burden on the health care system. This project will evaluate the genetic etiology of both rare and common craniofacial abnormalities using cutting edge genomic techniques in order to help both improve the screening of these disorders, as well as identify novel therapeutic targets. Furthermore, functional genomic analyses conducted during this project will help provide a clearer understanding of the biological mechanism behind aberrant craniofacial development.